Continuing to Support and Enhance an Integrated Food Safety System Through Implementation of Program Standards, Data Sharing, Collaboration, and State Training and Equipment Grants.

AFDO 2024 Alliance to Support the Activities of the Integrated Food Safety
System (IFSS), including the Grade A Milk Safety and National Shellfish
Sanitation Programs Application: Project Summary
The Association of Food and Drug Officials (AFDO) will direct and implement the activities
under this cooperative agreement which will facilitate FDA’s implementation of the Food Safety
Modernization Act (FSMA), help increase mutual reliance between agencies, help develop a
nationally Integrated Food Safety System (IFSS), and strengthen manufactured food, Grade A
Milk and shellfish sanitation programs, thereby improving public health protection of the food
supply. AFDO has been representing state regulatory food programs since 1896. The Principal
Investigator and project staff assigned to this project include former state food program
managers that have extensive experience developing state food safety programs, implementing
programmatic change to achieve conformance with the requirements of the MFRPS, and
collaborating with FDA to achieve a national IFSS.
Major activities conducted under this cooperative agreement include but are not limited to:
• Providing oversight and support to the Manufactured Food Regulatory Program Alliance
(MFRPA) to support state continuous improvement in the implementation of the
Manufactured Food Regulatory Program Standards (MFRPS);
• In collaboration with a joint advisory group, providing subaward funding for training and
equipment to state and territorial Grade A Milk and Molluscan Shellfish regulatory programs;
• Conducting research and surveys on the capabilities of state manufactured food programs;
• Researching and developing mechanisms to enhance data sharing;
• Maintaining and enhancing the secure online MFRPA Portal for sharing information and
data related to best practices, guidance documents, procedures, and other critical tools;
• Maintaining and enhancing directories for subject matter experts, food process authorities,
and directories of state and local regulatory officials, to improve interagency communication
and provide access to key contacts necessary for inter-agency collaboration in an IFSS;
• Collaborating to develop, deliver, and support state attendance at food safety and defense
training programs, including annual meetings for the MFRPA and Rapid Response Teams
(RRT), as well as web-based and face-to-face training courses designed to increase core
regulatory and scientific knowledge; and
• Researching methods to further promote food safety related regulatory careers with colleges
and universities and developing opportunities for experiential learning.

Public health relevance
AFDO 2024 Alliance to Support the Activities of the Integrated Food Safety System (IFSS), Including the Grade A Milk Safety and National Shellfish Sanitation Programs Application: Project Narrative The Association of Food and Drug Officials’ (AFDO) efforts under this cooperative agreement are intended to facilitate long-term improvements to the national food safety system by strengthening federal – state collaborations and improving state’s regulatory surveillance and protection programs for manufactured foods, Grade A milk, and shellfish sanitation programs. AFDO will support and contribute to the Manufactured Food Regulatory Program Alliance (MFRPA) as they work with states to develop best practices, develop and support training initiatives, and assist state programs in achieving programmatic improvement and conformance with the Manufactured Food Regulatory Program Standards (MFRPS). Through effective interagency collaboration, workforce development strategies, development of critical communication and data sharing strategies, and funding for state Grade A Milk and Shellfish program training and equipment, this project will help achieve a nationally Integrated Food Safety System (IFSS) and assist the U.S. Food and Drug Administration (FDA) in achieving their mandates under the Food Safety Modernization Act (FSMA).